Nanoelectrochemical Study of Molecular Transport through the Nuclear Pore Complex

Project Summary
In this proposal, we combine two powerful nanotechnologies, i.e., nanobodies and nanoscale scanning
electrochemical microscopy (SECM), to gain an unprecedented understanding of molecular transport through
the nuclear pore complex (NPC) as the sole gate between the cytoplasm and nucleus of a eukaryotic cell. We
engineer nanobodies from camelid-derived heavy-chain antibodies against distinct components of NPC, i.e.,
nucleoporins, to innovatively examine our hypotheses that are significant fundamentally in biology and
practically in biomedicine to synergistically advance human health care. The proposed work pioneers the
application of anti-nucleoporin nanobodies as selective blockers of NPC to reveal the unique role of each
nucleoporin in the regulation of nucleocytoplasmic molecular transport. We apply nanobodies to test our
original hypothesis that nucleoporins are heterogeneously distributed through the NPC nanopore to constitute
central and peripheral pathways. We employ nanoscale SECM developed in our laboratory to spatially resolve
nanobody-blocked and unblocked pathways based on low and high passive permeability to small probe ions,
respectively, thereby locating each nucleoporin within the nanopore. Furthermore, we apply nanobodies to
assess our new hypothesis that nucleoporins possess various populations of hydrophobic and charged amino
acids to sort out different macromolecules into different pathways not exclusively by hydrophobic interactions
as a long-standing consensus, but cooperatively with electrostatic interactions. We challenge the consensus by
investigating the passive transport of neurotoxic polydipeptides based on hydrophobic proline and cationic
arginine, which were recently found to block the NPC as a potential common cause of genetic
neurodegenerative diseases. We employ SECM to determine the high permeability of NPC to a proline–
arginine polydipeptide and its analogs with various hydrophobicity or charges. The measured permeability will
be affected differently by nanobodies that bind nucleoporins complimentarily or competitively with
polydipeptides. Accordingly, this study will provide the identity of nucleoporins targeted by polydipeptides in
addition to the type and strength of polydipeptide–nucleoporin interactions. These SECM studies of passive
transport lay the foundation for fluorescence transport studies of passively impermeable macromolecules,
which can be chaperoned through the NPC by nuclear transport receptors, i.e., importins, as a crucial step to
gene expression regulation and gene delivery. We employ nanobodies to determine whether importins
chaperon macromolecules through the peripheral pathway by utilizing both hydrophobic and anionic binding
sites to recognize peripheral nucleoporins with hydrophobic and cationic amino acids. In addition, we assess
whether the neurotoxicity of polydipeptides is related to their capability to block importin-facilitated
macromolecular transport. Overall, the proposed work will provide fundamentally novel chemical insights to
advance the rational design of genetic therapeutics for efficient and safe nuclear import through the NPC.

Public health relevance
Relevance We will fundamentally contribute to human health care by developing a greater understanding of molecular transport through the nuclear pore complex (NPC) of the cell nucleus. The NPC is crucial to gene expression regulation and is linked to many human diseases including cancers and neuronal diseases. We will reveal the chemical mechanism of nanoscale gating at the NPC to enable the efficient and safe delivery of genetic therapeutics into the nucleus.